WATER INDUCED SURFACE CHANGES IN SILICONE ELASTOMERS

ESCA will be utilized to detect and characterize degradation taking place during hot water treatment of silicone elastomers. The relation between temperature and rate of degradation will be established.